DelPhi: Software for Electrostatic Modeling of Biomolecules and Objects

DESCRIPTION (provided by applicant): The goal of this project is to maintain and further develop the existing software DelPhi (http://wiki.c2b2.columbia.edu/honiglab_public/index.php/Software:DelPhi). DelPhi provides numerical solutions to the Poisson-Boltzmann Equation (PBE) (both linear and non-linear forms) and calculates the corresponding energies for molecules and geometric objects immersed in water and salt phase or another continuum medium. Electrostatic forces are essential for the function, stability and interactions of virtually all biological macromolecules because most biological macromolecules, especially DNA and RNA, are highly charged. The role of electrostatics is two fold: providing long-range interactions steering biological molecules toward their pre-binding orientations and contributing to the specificity by strong short-range direct interactions. In addition, many biologically important effects such as pH and salt dependence effects are primarily electrostatic in nature. Moreover, the constant progress of nanotechnology requires modeling of systems made of biological molecules and charged metal/dielectric surfaces and objects. Thus, accurate calculations of electrostatic fields and energies are crucial for successful modeling of virtually all biological processes and many other phenomena occurring in nanosystems and nanodevices. We propose to maintain and further develop the DelPhi, the first PB solver used by many researchers as is shown in the main body of the proposal. In addition to the existing features such as assigning different dielectric constants to different regions of space, modeling geometrical objects and charge distributions, treating systems containing mixed salt solutions, we plan to develop new options as modeling implicit/explicit membrane, predicting explicit ion binding and new geometrical objects. In parallel we will modernize the code and the corresponding algorithms and will facilitate interactions with our users.

Public health relevance
PUBLIC HEALTH RELEVANCE: Electrostatics is essential for function, stability and interactions of virtually all biological macromolecules, including receptor-drug recognition. The central role of electrostatics is due to the fact that most biological macromolecules are highly charged, because they contain many charged amino acids which in turn are essential for structure, function and interactions of variety of biomolecules. Many biologically important effects such as pH and salt dependence effects are primarily electrostatic in nature. Therefore an accurate modeling of electrostatic potential and the corresponding energies is critical for successful drug discovery and optimization. Relevance to Human Health (Project narrative) Electrostatics is essential for function, stability and interactions of virtually all biological macromolecules, including receptor-drug recognition. The central role of electrostatics is due to the fact that most biological macromolecules are highly charged, because they contain many charged amino acids which in turn are essential for structure, function and interactions of variety of biomolecules. Many biologically important effects such as pH and salt dependence effects are primarily electrostatic in nature. Therefore an accurate modeling of electrostatic potential and the corresponding energies is critical for successful drug discovery and optimization. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS The goal of this project is to maintain and further develop the existing software DelPhi (http://wiki.c2b2.columbia.edu/honiglab_public/index.php/Software:DelPhi). DelPhi provides numerical solutions to the Poisson-Boltzmann Equation (PBE) (both linear and non-linear forms) and calculates the corresponding energies for molecules and geometric objects immersed in water and salt phase or another continuum medium. Electrostatic forces are essential for the function, stability and interactions of virtually all biological macromolecules. The central role of electrostatics is due to the fact that most biological macromolecules, especially DNA and RNA, are highly charged. Long-range electrostatic interactions steer biological molecules toward their pre-binding orientations. Charged groups are essential for the structure, function and interactions of proteins, but their probability to be charged (directly connected to their pKa's) is frequently perturbed in proteins due mostly to electrostatic effects. Many biologically important effects such as pH and salt dependence effects are primarily electrostatic in nature. Moreover, the constant progress of nanotechnology requires modeling of systems made of biological molecules and charged metal/dielectric surfaces and objects. Thus, accurate calculations of electrostatic fields and energies are crucial for successful modeling of virtually all biological processes and many other phenomena occurring in nanosystems and nanodevices. One of the main problems in modeling the electrostatic potential of biological macromolecules is that they exist in water at a given ionic strength and that they have an irregular shape. Analytical solutions of the corresponding PBE are not available for such cases and the distribution of the potential can be found only numerically. DelPhi, available since 1986, was the first PBE solver used by many researchers as is shown in the main body of the proposal. The widespread popularity of DelPhi is due to its speed, accuracy (calculation of the electrostatic free energy is only slightly dependent on the resolution of the grid) and the ability to handle extremely high grid dimensions. Additional features such as assigning different dielectric constants to different regions of space, modeling geometric objects and charge distributions, and treating systems containing mixed salt solutions also attracted many researchers. In addition to the typical potential map, DelPhi can generate and output the calculated distribution of either the dielectric constant or ion concentration, providing the biomedical community with extra tools for their research. Currently we distribute DelPhi, both the source code and executable, for all major operating systems allowing users to better exploit their own computing resources. In order to ensure the continuing availability of DelPhi package to the biomedical community, we request funding to pursue the following specific aims: Aim 1: Rewriting the existing DelPhi code in C++ programming language and modernizing the corresponding algorithms. This will facilitate the development of new modules by third parties and will enable better maintenance of the code by currently available on the market software specialists. Core numerical routines will be made parallel and suitable for High Performance Computing systems. Aim 2: Development of new features facilitating biomolecular modeling. These include implicit and explicit modeling of biological membranes, prediction of explicit ion binding and new geometric objects and charge distributions. Aim 3: Continuous work toward keeping the DelPhi package user-friendly and incorporating pre- processing units to import different formats, check for consistency and prepare 3D structures for calculations. We will test the new version against the existing examples, and create examples for the newly developed features described in Aim 2. In parallel, work will be done to make the format of the potential, dielectric and concentration map output files suitable to be imported by existing graphical software. Aim 4: Continuous expansion of DelPhi user basin by facilitating interactions between developers and users, and between users themselves. We will further develop the DelPhi manual to include the new features and examples. We will also create an information rich web page as a Wiki discussion forum and organize bi-annual workshops for DelPhi users.